fMRI Investigations of Cognition in Alcoholics

DESCRIPTION (provided by applicant): The goal of this project is to better understand the changes in cerebro-cerebellar brain function that occur after chronic alcoholism. Using verbal and spatial working memory as model paradigms for investigating cognitive- related cerebro-cerebellar function, our preliminary investigations have suggested that alcoholism can produce either decreases in activation or increases that may be compensatory in nature. We propose to further investigate alcohol-related changes in activation using event-related functional magnetic resonance imaging (fMRI) methods designed to shed more light on the nature of alcohol-induced neuropsychological deficits. Our working memory paradigm is comprised of 3 distinct task phases of encoding, maintenance, and retrieval of information. It has not been determined whether changes in brain activation observed thus far in alcoholics are derived from one or more of the cognitive demands occurring during these task phases. Specifically, differences in activation we have observed could be due to differences in the ability to acquire sensory input and encode verbal information (encoding), differences in rehearsal of information (maintenance), differences in the executive utilization of the maintained information (retrieval), or a combination of these three. We will use event-related fMRI to examine phase specific differences caused by alcoholism, and we will introduce phase- specific challenges to further examine process-specific changes in regional cerebro-cerebellar activation that differ between alcoholic and non-alcoholic subjects. We will also investigate possible dissociations of verbal and spatial working memory on alcohol-related changes in cerebro-cerebellar activation. Whereas spatial working memory in alcoholic subjects has revealed decreases in frontal lobe activation, verbal working memory has elicited left frontal and right cerebellar increases in activation. We propose to investigate whether these different patterns reflect differences in tasks across studies, differences in alcoholic populations, or differences in the effect of alcohol on neural substrates underlying verbal and spatial working memory. Finally, scans designed to measure blood flow, blood volume, and blood oxygenation will be used to determine to what extent BOLD signal differences in the populations are influenced by vascular and/or metabolic changes. These investigations will provide a better understanding of how chronic alcoholism changes brain function underlying cognition.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic alcoholism is known to cause structural changes in the brain, but little is known about the effects of alcoholism on brain function underlying cognitive performance. The experiments in this proposal are designed to characterize, using functional MRI and tasks of verbal and spatial working memory, differences between alcoholics and non-alcoholics in brain function underlying these fundamental cognitive processes. Chronic alcoholism is known to cause structural changes in the brain, but little is known about the effects of alcoholism on brain function underlying cognitive performance. The experiments in this proposal are designed to characterize, using functional MRI and tasks of verbal and spatial working memory, differences between alcoholics and non-alcoholics in brain function underlying these fundamental cognitive processes. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS The overall goal of this research is to characterize differences between alcoholics and non-alcoholics in cerebro-cerebellar brain function underlying cognitive performance using functional magnetic resonance imaging (fMRI) with tasks of human working memory. The cerebellum has long been thought to be exclusively involved in motor control, but neuroimaging studies have demonstrated cerebellar activation occurring in tandem with neocortical activation during a number of different cognitive tasks. Preliminary investigations in our laboratory suggest that the function of such cerebro-cerebellar circuits during a verbal working memory task changes as a result of chronic alcohol consumption. Because the task that we used involves distinct phases of encoding, maintenance, and retrieval of verbal information, further investigation of alcohol/control activation differences at each phase will shed more light on the nature of alcohol-induced neuropsychological deficits. Specifically, the differences in activation that we observed could be due to differences in the ability to acquire sensory input and encode verbal information (encoding), differences in the articulatory control system subserving the subvocal rehearsal of verbal information (maintenance), differences in the utilization of the maintained information (retrieval), or a combination of these three. We propose to investigate the nature of the alcohol-related changes in working memory activation in two specific aims. Using alcoholic and non-alcoholic volunteer subjects, we will: Aim 1: Characterize changes due to alcoholism in functional activation during a verbal working memory task. We will scan subjects while they perform a Sternberg [210] verbal working memory task with discrete stages of encoding, maintenance, and retrieval. Using event-related fMRI and subject-specific measures of hemodynamic response functions, we hypothesize that regions of the cerebellum involved with sensory acquisition will be activated during the encoding phase; regions involved in motor control/error correction will be activated during the maintenance phase; and regions involved in executive decision will be activated during the retrieval phase, and that alcoholics and non-alcoholics will differ during one or more phases of the task. Aim 2: Characterize the effects of alcoholism on task phase-specific challenges during verbal working memory. By increasing cognitive demands separately during encoding or maintenance or retrieval phases, we hypothesize that corresponding process-specific increases in regional cerebellar activation that differ between alcoholic and non-alcoholic subjects will be revealed. We will perform separate experiments that (a) challenge the sensory acquisition component of the task by increasing stimulus rate and by decreasing stimulus integrity; (b) challenge the maintenance component of the task by increasing phonological similarity and duration of time of storage; and (c) challenge the executive component of the task by increasing the required manipulation of the stored information. Aim 3: Characterize dissociations of spatial and verbal working memory in alcohol-related changes in cerebro-cerebellar activation. In our previous investigation of spatial working memory in alcoholic subjects [175], we observed substantial decreases in frontal lobe activation in alcoholics relative to non-alcoholic controls. In contrast, our investigation of verbal working memory related brain activation [48] revealed left frontal and right cerebellar increases in activation in alcoholics relative to non-alcoholics. These different patterns of results suggest that alcoholism may not have a simple effect of either uniformly increasing or decreasing brain activation in all tasks, and that the effect of alcoholism on brain activation may be both task and region dependent. Because the previous investigations of verbal and spatial working memory were conducted on different alcoholic populations, with potentially different amounts of brain atrophy or other differences, we propose to investigate whether the same dissociation of the effects of chronic alcoholism on verbal and spatial working memory activation can be revealed in the same population of alcoholic subjects. Upon successful completion of this project, we expect to have a better understanding of the effects of chronic alcoholism on processes that influence cerebro-cerebellar activation for higher cognitive function (sensory acquisition, motor control/error correction, and executive decision), and a better understanding of verbal/spatial working memory dissociations on alcohol-related changes in brain activation. These results will provide a better understanding of how alcoholism alters cognition and its underlying brain function.